Mechanisms and significance of programmed cell death in hypothalamic CRH neurons

PROJECT SUMMARY/ABSTRACT
Corticotropin-releasing hormone (CRH) expressing neurons in the hypothalamus are critical regulators of the
neuroendocrine stress response. CRH neurons integrate stress-related neural inputs and, as part of the
hypothalamic-pituitary-adrenal (HPA) axis, induce the release of ACTH and, ultimately, glucocorticoids
(cortisol). The development of CRH neurons is of great biomedical interest, as developmental vulnerabilities of
CRH neurons contribute to stress-associated disorders such as anxiety and depression. It is, therefore, critical
to identify the molecular and cellular mechanisms mediating the development of CRH neurons and determine
how developmental changes affect stress response. Using zebrafish, which are genetically accessible and
optically translucent, we found that DSCAML1 deficiency impaired the developmental cell death of CRH
neurons and caused hyperactivation of the HPI axis (the zebrafish analog of the HPA axis). Given that
DSCAML1 is known to mediate intercellular interactions, we hypothesize that proximity-based and synaptic
interactions in CRH neurons trigger developmental cell death, which tunes the activity of the neuroendocrine
stress response system. To test this, we propose the following aims. In Aim 1, we will test whether
proximity-based interactions promote cell death in CRH neurons. Using the live imaging strength of the
zebrafish model, we will examine whether interactions between adjacent CRH neurons promote cell death and
determine how varying levels of DSCAML1 modulate the extent of cell loss. In Aim 2, we will test whether
synaptic interactions affect CRH neuron cell death. Synaptic activity plays an instructive role in neuronal
survival. Given DSCAML1’s known functions in synaptogenesis, we will investigate whether CRH neuron
survival is dependent on neuronal activity and how DSCAML1-mediated synaptogenesis controls the
excitability of CRH neurons. In Aim 3, we will test how DSCAML1 acts within CRH neurons to trigger cell
death and establish HPI-axis activity. Using CRH neuron-specific mutants, we will determine how DSCAML1
functions within CRH neurons and whether DSCAML1’s function in other cell types also contributes to HPI-axis
development. In Aim 4, we will test the hypothesis that CRH neuron number tunes HPI-axis activity.
While the significance of cell death is widely recognized, the functional impact of CRH neuron cell death has
not been explored. We will use genetic tools to increase or decrease CRH neuron number and determine the
causal relationship between cell number and HPI-axis activity. Together, these aims will shed light on how
intercellular interactions influence CRH neuron cell death and provide a molecular framework for future
molecular studies.

Public health relevance
PROJECT NARRATIVE Our body’s stress response system helps us adapt to everyday stressors, but maladaptive stress responses can cause stress-associated disorders such as anxiety and depression. To develop new therapies for stress- related disorders, it is critical to uncover the fundamental molecular and developmental mechanisms for stress response regulation. This proposal will elucidate how neuronal cell death is triggered within the stress response pathway and determine whether the extent of cell death determines the level of stress response pathway activation.